Northwell Roybal Center for Personalized Trials: Physical Activity Promotion for Persons Giving Care or Living with AD/ADRD

PROJECT ABSTRACT
The goal of this Northwell Roybal Center for Personalized Trials: Physical Activity Promotion for
Persons Giving Care or Living with AD/ADRD is to generate behavioral intervention development research
for enhancing physical activity (Roybal Theme: Spur the Initiation and Maintenance of Physical Activity
Regimens that are Personalized to Caregivers or Persons with AD/ADRD). The Northwell Roybal Center is
comprised of two components: the Administrative Core and the Behavioral Intervention Development Core.
Our Administrative Core will develop and provide the strategic vision, leadership, and the full range of NIH
Stage Model expertise needed for the success of this Roybal Center; monitor Center clinical trials progress
and provide immediate feedback; develop, identify, and use common metrics for Center productivity evaluation
purposes. Finally, the core will facilitate collaboration with other Roybal Centers, the Coordinating Center, the
National Institute on Aging, and scientists across the nation interested in advancing the initiation and
maintenance of physical activity regimens personalized to care providers or those living with AD/ADRD.
Our Behavioral Intervention Development (BID) Core will proactively determine a national pool of potential
eligible scientists for later national competitions, review and select meritorious clinical trials for funding, and
ensure compliance of all clinical trials with all regulatory agencies. The BID will then support investigators
identified via this national competition to implement identified innovative clinical trials that align with the themes
of the Northwell Roybal Center in Years 3 through 5 of the proposed project. The BID Core will also support
the conduct of two Stage II fully-powered clinical trials in Years 1 and 2 that aim to foster habitual physical
among caregivers for persons with AD/ADRD. Trial #1 will work to develop habitual daily walking among
caregivers. In contrast, Trial #2 will develop habitual hourly walking to reduce the amount of time caregivers
spend sedentary. Both trials will measure the key mechanism of behavior (MoBC) of cognitive automaticity.
The overall mission of the Northwell Roybal Center for Personalized Trials is to establish an infrastructure
organized per the NIH Stage Model with scientiﬁc expertise and resources to conduct Stages 0-V trials of the
translational behavioral intervention development pipeline, as well as examining key MoBCs of behavior
change, and so serve as a national resource for the behavioral and social intervention research community in
initiating and maintaining personalized physical activity regimen for caregivers or persons living with
AD/ADRD.

Public health relevance
PROJECT NARRATIVE This Northwell Roybal Center for Personalized Trials: Physical Activity Promotion for Persons Giving Care or Living with AD/ADRD aims to generate behavioral intervention development research for enhancing physical activity among individuals with AD/ADRD and the people who care for them. The Northwell Roybal Center will execute this mission through the Administrative Core, which will develop and provide the strategic vision, leadership, and full range of expertise needed for the success of this Roybal Center, and the Behavioral Intervention Development Core, which will identify and supervise the conduct of innovative clinical trials informed by the NIH Stage Model and the Roybal Center Themes.